Machine Learning and Large-scale Imaging analytics for dimensional representations of brain trajectories in aging and preclinical Alzheimer's Disease: The brain aging chart and the iSTAGING consortium

Abstract
The parent grant has been building a truly unique database of MRI, clinical and cognitive data from over
65,000 individuals and 16 distinct studies. It has been constructing machine learning models and
biomarkers aiming to capture the heterogeneity of brain aging and derive predictive models of cognitive
decline. The current supplement will build the foundation for making these pipelines available very easily
through cloud computing. More specifically, the focus of this supplement will be to build the infrastructure
for a web-based portal running n the AWS cloud, which will allow for seamless “drag-and-drop” of MRIs
for application of the pipelines developed by the parent program. This will facilitate the wide access of
these pipelines without the need to set up local software and familiarize with complex preprocessing of
MRI datasets and machine learning pipelines.

Public health relevance
Project narrative The parent proposal pools imaging data from 26 different studies, aiming to obtain a comprehensive characterization of brain aging via machine learning methods applied to imaging and clinical data. In the current supplement, we propose to specifically build a cloud-based web portal that will allow for easy web access to the pipelines, models and brain maps created by the parent project.